4/6 Planning for the HEALthy Early Development Study

R34 Parent Grant Abstract (Chambers, PI) The Planning for the HEALthy Early Development Study will contribute to the design and recommended protocol for a future large-scale, multi-site research study to prospectively examine human brain, cognitive, behavioral, social and emotional development of children beginning prenatally through ages 9-10, and to determine the impact of maternal pre- and postnatal substance use on short- and long-term development of children. The Planning Study will link investigators across 6 research sites who have complementary experience and expertise in the areas that are essential to designing the study. Planning activities will be accomplished using a coordinated set of 10 Working Groups who will work collaboratively to design a sampling and recruitment strategy for a future large-scale study, to identify and recommend strategies for addressing the challenges to ethical recruitment and retention of vulnerable populations, and to develop and test a common protocol for neuroimaging, infant and child assessments, exposure assessment, biospecimen collection, and integration of novel technologies. By the end of the Planning Phase, the 6 Consortium sites will have produced and tested a recommended protocol for the future multi-site study, and will have established feasibility of carrying out the study protocol at each of the 6 linked sites.

Public health relevance
Project Narrative – Supplement The HBCD study will involve pervasive sensor and other emerging biotechnologies to capture personal health behaviors, including sleep, respiration, weight and, potentially, reportable behaviors. Our current scope of work for the planning grant (parent R34) does not include research to expand our knowledge of the ethical, legal and social implications (ELSI) of integrating wearable, remote or implanted sensor technologies for the purpose of gathering biological, behavioral and environmental data 24/7 in real time from study participants. This HBCD bioethics supplement will build upon our current planning grant by engaging Consortium stakeholders from our 6-linked sites in the development and testing of decision support tools and processes for improving health tech literacy among those whom we will enroll in the large-scale and longitudinal study of children.